Modifiers of sensorineural hearing loss

Project Summary
Congenital deafness is among the more prevalent chronic conditions seen in human infants, and genetic
causes are thought to explain the majority of cases in developed countries. While progress has been made in
identification of primary deafness causing genes, it is also evident that no given gene mutation acts alone. That
is, additional variants throughout the genome (genetic modifiers) result in a spectrum of phenotypic outcomes.
These modifiers are important to understand because they reveal new cellular and molecular mechanisms that
participate in a phenotype of interest. They are also important for diagnostic, prognostic, therapeutic and
patient management strategies. So far, there is no insight as to what these modifiers are or how they act.
Waardenburg-Shah syndrome (WS4) is an example in which hearing loss is an incompletely penetrant trait
within the larger group of patients with Hirschsprung disease (congenital gut motility disorder). Both are
associated with mutations in endothelin signaling genes. As described in a recently published study, we
recapitulated the variable penetrance of hearing impairment in endothelin signaling gene mutant mice by
utilizing the genetically diverse outbred ICR strain background. We also determined that the primary cause of
hearing impairment in these mice is in auditory synaptic function, and demonstrated unique and independent
roles of endothelin signaling in spiral ganglia neurons and glia.
This project seeks to identify genetic modifiers that influence the penetrance of hearing impairment in the
context of endothelin receptor Ednrb deficiency. We performed a large scale genome wide association analysis
which is uniquely possible with our mice, and identified two lead candidate genes that are presented here for
further exploration. In Aim 1, we address the role of the gene Kcnj16 (encoding the potassium channel Kir5.1),
which we propose influences hair cell excitability and auditory neuronal maturation. In Aim 2, we explore
neuronal Dchs2 (which encodes a cadherin-type adhesion molecule) and address how it influences auditory
synapse formation and function.
The results from this study will elucidate genetic components of phenotypic heterogeneity and will reveal new
mechanisms that are involved in auditory function. The experimental material is specific for WS4, although the
insights are likely to be relevant to a much broader range of congenital hearing disorders in mice and humans.

Public health relevance
Project Narrative The majority of human congenital hearing impairment is attributed to genetic causes, which involves known disease-associated genes coupled to the influence of unknown phenotype modifiers. Identification of these modifiers will expose new mechanisms relevant to normal auditory development in all mammals, including humans, and may lead to improved diagnostic criteria and therapeutic opportunities in disease. An already- completed large-scale genome-wide association study in a mouse model of human congenital hearing loss led to the two novel candidate modifying genes that will be evaluated in this project.